The impact of aged-related dermal microenvironment on the development of precancerous stroma and cancer initiation

This application is being submitted in response to the Notice of Special Interest (NOSI) identified as NOT-
CA-24-029. Cancer is clearly a disease of aging. This is especially true in the case of skin cancer, which
is the most common form of human cancer, accounting for more than all other cancers combined in the
USA. The major objective of this U01 Supplement application is a mechanistic understanding of the
interactions between age-related changes in the dermal microenvironment and infiltrating immune cells
in the initiation of keratinocyte cancer. This application is based on the findings from our humanized
mouse model of tumor initiation in our accelerated dermal aging mouse model. This model expresses the
matricellular protein CCN1 in dermal fibroblasts and oncogenic HRas in epidermal keratinocytes. CCN1
expression in dermal fibroblasts (the source of elevated CCN1 in aged human skin) drives strikingly
accelerated dermal aging, characterized by fragmentation and disorganization of the collagenous dermal
extracellular matrix, and an aged fibroblast phenotype typified by reduced ECM production and increased
expression of pro-inflammatory mediators. The age-related dermal microenvironment enhances the
tumorigenic potential of oncogenic HRas and results in squamous cell cancer-like tumorigenesis.
Importantly, at the early stage of tumor initiation, we find substantial infiltration of activated immune cells
into the dermis in close approximation to the dysplastic precancerous epidermis. Therefore, we
hypothesize that the interactions between the aged-dermal microenvironment and infiltrating immune cells
critically enable tumor initiation. We propose to test this hypothesis by determining the global gene
expression profiles in individual dermal fibroblasts and infiltrating immune cells in situ in the context of
their localization within the precancerous dermis. This aim will be accomplished by using the newly
developed most advanced spatial gene expression technology, Visium HD. Visium HD has a spatial
resolution of 2µm, which can reveal the comprehensive gene expression of individual cells and their
locations within the dermis. Thus, we will investigate the impact of the interactions between immune cells,
fibroblasts, and the dermal microenvironment during tumor initiation. For these studies Dr. Evan Keller
will join our research team. Dr. Keller is a Professor of Urology and Pathology and the Director of the
University of Michigan Medical School Single Cell Spatial Analysis Program and Co-director of The
Rogel Cancer Center Single Cell and Spatial Analysis Shared Resource. He will provide oversight of the
Visium HD spatial studies, data acquisition, quality control, data interpretation and management of
personnel. We are confident that the proposed study will provide novel insights into the cellular and
molecular mechanisms by which the interactions between the aged dermal microenvironment and
infiltrating immune cells act in concert to initiate skin carcinogenesis.

Public health relevance
Project Narrative Emerging data from our parent grant support the novel concept that age-related detrimental changes in the dermal compartment drive skin cancer initiation. The aged dermis drives cancer initiation, in part, by influencing the functions of skin immune cells. This supplemental proposal seeks to use the most advanced high-definition spatial gene expression tools to extend the findings of the parent grant by examining the interactions of immune cells with the aged dermis during cancer initiation.